Epidemiology of the gut-liver axis and hepatocellular carcinoma risk in a multiethnic liver cirrhosis cohort: defining the role of bacteria, metabolites, and glycoproteins

PROJECT SUMMARY
Hepatocellular carcinoma (HCC) is the most common type of liver cancer in adults in which most cases
develop in patients with liver cirrhosis. The incidence and mortality of HCC is rising and showing widening
disparities, with the Latinx population having the greatest increase over the last decade. Latinxs represent 19%
of the total U.S. population, comprise the largest racial/ethnic group in California (CA, 40%), and are notably
underrepresented in current research into biomarkers for HCC. Notably, HCC in U.S. born Latinxs from Mexico
is double that of Mexican-born individuals, underscoring the importance of social, behavioral, and
environmental risk factors on hepatocarcinogenesis. In our preliminary research using the Microbiome,
Microbial Markers, and Liver Disease (M3LD) Study, a multicenter prospective cohort of individuals with liver
cirrhosis recruited across CA, we published the first-in-human evidence showing a role for the gut-liver axis in
HCC risk. We identified a duodenal microbe (Alloprevotella), circulating metabolites (methionine and
methionine sulfoxide), and bile acid (taurocholic acid) that were associated with subsequent diagnosis of HCC.
We found a Latinx ethnicity-specific microbiome composition in participants with cirrhosis, and we showed that
dietary factors previously associated with reduced HCC risk (healthy eating index, coffee, fiber, and protein)
were associated with Latinx ethnicity and significant microbial differences in participants with cirrhosis at risk of
HCC. Based on these preliminary results, this study proposes to expand the M3LD cohort by enrolling ~1000
participants with liver cirrhosis enriching for the Latinx population, who will be followed prospectively for HCC
development. We will collect duodenal biopsy and blood specimens, clinical data, and epidemiological data.
We will characterize the duodenal barrier and identify novel bacteria and glycans, and probe for microbial-
related serum immune markers and metabolites. The overall goal is to apply a rigorous experimental design
that will reveal mechanisms that influence HCC risk in the Latinx population, ultimately leading to the
identification of novel biomarkers for risk assessment and targets for HCC prevention, and a disparity
reduction.

Public health relevance
PROJECT NARRATIVE There are increasing incidence and mortality rates for hepatocellular carcinoma (HCC) in the United States that are disproportionately impacting the Latinx population for poorly understood reasons. This study will recruit individuals with liver cirrhosis, precursor for liver cancer, to explore mechanisms of the gut-liver axis that contribute to HCC risk and will provide critical information for future HCC mitigation and prevention strategies.